Aberrant Glycogen Modulates Cerebral Glucose Metabolism in Aging and Alzheimer's Disease

Abstract:
The onset of Alzheimer's disease (AD) increases in incidence with age, and an increasing aging demographic
means the number of individuals suffering from AD is expanding rapidly. Changes in cerebral metabolism are
hallmarks of aging therefore it is reasonable to hypothesize that age-associated change in metabolism play
major roles in AD progression. AD brains show clear metabolic impairments, and studies suggest that altered
metabolism drives a cascade of events leading to AD onset. The mechanisms initiating these metabolic
impairments remain a critical knowledge gap in AD research. We recently discovered that aberrant glycogen
aggregates (AD-glycogen) are a universal feature of AD in both human and mice. Increases in AD-glycogen
correlated with higher Braak staging and lower glucose levels in patient specimens. AD-glycogen is both
hyper-phosphorylated and hyper-branched making them architecturally distinct from normal glycogen. We
present strong evidence showing that AD-glycogen modulate brain metabolism through direct binding and
inactivation of the AMP-activated protein kinase (AMPK), a master regulator of central carbon metabolism. We
will first elucidate the molecular events leading to abnormal AD-glycogen formation in vitro and in vivo (Aim 1),
then we will interrogate the impact of AD-glycogen on cerebral metabolism during aging (Aim 2). Finally, we
will assess the efficacy of a novel glycogen-clearing enzyme therapy on brain metabolism, cognition, and AD
neuropathology in vivo (Aim 3). The PI has assembled a multi-disciplinary team of investigators with
complementary skillsets and state-of-art, high resolution, and Omic-based techniques to discover potential
therapeutic options and possibly treat the onset of AD.

Public health relevance
Project Narrative Cerebral glucose hypometabolism is now considered one of the hallmarks of Alzheimer’s disease (AD), clinical AD symptoms almost never occur in the absence glucose hypometabolism, and the extent of the metabolic changes measured strongly correlate with the severity of clinical symptoms. The mechanism(s) that drive glucose hypometabolism remain a critical knowledge gap in AD research. This proposal aims to examine age- related changed in cerebral glucose metabolism in both healthy and AD mouse models to 1) improve our understanding in the metabolic aging process and 2) to identify divergent events that result in the onset of AD from the aging population.